SEVERE HYPOXEMIA ASSOCIATED LIVER DISEASE-- THERAPEUTIC EFFECTS OF SOMATOSTATIN

To confirm an unpublished report that somatostatin causes dramatic resolution of severe hypoxemia associated with liver disease.